Administrative Core

Administrative Core - The administrative core is responsible for all administrative aspects of the Center. These responsibilities include: managing the growth of the Center's membership, hiring and managing staff, managing the Center's communications products and information channels, and managing the budget.